Multilevel Determinants of Socioeconomic Disparities in Geographic Late Stage Hepatocellular Carcinoma Hotspots

PROJECT SUMMARY/ABSTRACT
Hepatocellular carcinoma (HCC) is the fastest growing cause of cancer-related deaths in the United States
(US), with rising incidence among low-income individuals. Due to importance of cancer stage at diagnosis to
survival, we applied small area estimation to the population-based cancer registry in urban Los Angeles
County (LAC) to identify areas of highest late stage HCC burden for intervention. These geographic late stage
HCC “hotspots” were disproportionately concentrated in areas of lowest socioeconomic status (SES). Few
strategies to promote the early detection of HCC have been studied and most are not tailored to the low SES
populations that experience the greatest disparity. The scientific objective of this proposal is to address this
need by characterizing the individual-, organizational-, and community-level determinants of the geographic
aggregation of late stage HCC in low SES communities. Specifically, we propose to use geospatial techniques
to refine our population-based late stage hotspots and perform sensitivity analyses around spatial, clinical, and
temporal inputs (Aim 1). We will analyze a multilevel dataset built from prospective survey, medical record, and
geospatial linkage of 700 incident HCC registry cases to identify the root determinants of SES disparities (Aim
2). Last, semi-structured interviews will be conducted at multiple levels (e.g., patients, providers, and
community leaders) to explore barriers to completion of the early detection pathway for HCC in low SES
populations (Aim 3). Study constructs are conceptually grounded in the National Institute on Minority Health
and Health Disparities Framework, with interviews guided by the Multi-Level Health Outcomes Framework.
Together, our rich theory-driven data will directly inform the strategic plan for a multilevel early detection pilot
intervention targeting late stage HCC hotspots in a future R34, followed by a cluster randomized controlled
intervention trial in a R01. The training objectives in this proposal will foster Dr. Zhou’s growth as a cancer
disparities researcher focused on geospatial innovation in early detection strategies to mitigate disparities and
improve outcomes among underserved populations with HCC. The four core components of Dr. Zhou’s training
plan combine advanced didactics with applied experience: (1) proficiency in spatial methodology and
geovisualization; (2) foundation in multilevel modeling and qualitative methods to support effective disparities
research; (3) introduction to multilevel intervention design and delivery; and (4) professional development in
cancer disparities. Dr. Zhou has access to an academic research environment enriched for cancer disparities
and cancer control research, a socioeconomically diverse urban population in LAC, and a strong
transdisciplinary mentorship team, comprised of primary mentor Dr. Cockburn (spatial sciences and cancer
control) and co-mentors Dr. Mack (multilevel modeling), Dr. Bastani (multilevel interventions), and Dr. Terrault
(career development). In summary, this proposal embeds detailed training goals within a practical sequence of
research aims to provide Dr. Zhou with a clear path to investigator independence.

Public health relevance
PROJECT NARRATIVE Liver cancer, a gastrointestinal cancer of poor prognosis, is rising among low-income Americans, who are more often diagnosed at late stages and experience lower survival. This research proposal is designed to disentangle the complex reasons that underlie the geographic clustering of late stage liver cancer diagnoses within communities of lower socioeconomic status. Our findings will contribute to the development of effective and tailored intervention strategies to increase the early detection of liver cancer in at-risk adults living in the most disadvantaged areas, and consequently, the important public health mission of achieving equitable cancer outcomes.